Administrative Core

SUMMARY ADMINISTRATIVE CORE
Collaborative science faces unique challenges that parallel the size and scope of the project or Program. Beyond
increased scientific challenges (such as data integration and harmonization), so too do the challenges to
coordinate, communicate, and collaborate effectively within the Program increase. The proposed project includes
four major research projects, supported by three resource cores, executed by a diverse multi-disciplinary team
distributed across five research institutions. The goal of this Administrative (Admin) Core is to facilitate their
coordination, communication, and collaboration. Our leadership team has extensive experience coordinating and
managing large, multi-investigator programs; most notably as a small animal testing center in Somatic Cell
Genome Editing (SCGE) Phase I funding, and as a precision genetics center (JAX Center for Precision Genetics,
JCPG) improving animal models of human disease and move them towards translation to the clinic. In each of
these programs, we have established frameworks for organizing our teams, sharing information across projects
and institutions, tracking progress and milestones, and communicating progress to key stakeholders as well as
the NIH program officers. Our previous experience leading Administration/Coordination Cores for multi-
institutional, NIH-funded Programs makes us uniquely qualified to develop and execute on the administrative
goals of this U19. The Admin Core will provide managerial and administrative structure for this U19 Program
through the following Aims. In Aim 1 we establish an effective administrative governance structure to assure
success of this U19 Program. We use prior experience and Program-specific characteristics to build a clear
hierarchy of governance and include guidance from clinical experts in neurodegenerative diseases to hasten
IND application. In Aim 2 we develop a formal meeting schedule to foster the communication needed to execute
on the goals of this proposal. The Admin Core will be responsible for managing this schedule, recording, and
reporting out on the progress and action items identified in these meetings. The Admin Core will use these
reports to monitor progress toward milestones of the Program and each Project for Aim 3, assisting NIH Program
officials in their alignment of our Program with SCGE Phase II. Finally, the Admin Core will communicate the
findings from this U19 Program with the Translational Coordination and Dissemination Center for external
distribution and assist in the creation of a shared learning and training education hub.